CD39-carrying extracellular vesicles regulate pulmonary thrombosis in Sickle Cell Disease

PROJECT SUMMARY
Sickle cell disease (SCD) is the most common hemolytic disorder affecting African Americans. In situ (de novo)
acute pulmonary thrombosis is the underlying cause in ~20% of SCD patients hospitalized with respiratory
failure. The current therapy for pulmonary thrombosis in SCD is primarily supportive and a preventive therapy
does not exist. Autopsy and computed tomography studies have identified that occlusion of pulmonary arterioles
by platelet-rich thrombi contributes to development of pulmonary thrombosis in SCD patients. Adenosine
diphosphate (ADP) released from lysed erythrocytes activates platelets by stimulating purinergic P2Y1 and
P2Y12 receptors. We recently discovered that this pathway promotes pulmonary thrombosis following acute-
hemolysis in control mice, suggesting that ADP-induced purinergic signaling may also promote pulmonary
thrombosis in SCD. However, P2Y12 receptor antagonists have shown no benefit to SCD patients in recent
clinical trials, and it remains unknown why pulmonary thrombosis develops only in a sub-set but not all SCD
patients. Identifying molecular and genetic mechanisms that trigger pulmonary thrombosis in SCD, would enable
the development of Precision Medicine diagnostic and therapeutic approaches for these at-risk SCD patients.
Based on our new preliminary findings, we hypothesize that CD39 (ecto-nucleotidase) present in circulating
extracellular vesicles (EVs) degrades excess ADP to prevent pulmonary thrombosis in SCD, however, single-
nucleotide-polymorphism (SNP) rs3176891G in the CD39-encoding gene (ENTPD1) attenuates this protection
and identifies SCD patients who can benefit from anti-purinergic therapy. We will test this hypothesis using our
newly developed mouse model of pulmonary thrombosis triggered by intravenous (IV) administration of ADP, in
vivo imaging of lung in live mice, in vitro microfluidic studies with SCD patient blood, isolation and characterization
of EVs, SCD mice genetically deficient in CD39, and genetic analyses in SCD patients with vs without SNP
rs3176891G. In Aim 1, we will determine whether ADP-induced platelet aggregation and pulmonary thrombosis
is impaired in SCD. In Aim 2, we will determine whether CD39-carrying circulating EVs degrade excess ADP to
prevent pulmonary thrombosis in SCD. In Aim 3, we will determine whether SNP rs3176891G promotes
pulmonary thrombosis event in SCD patients by attenuating CD39-carrying EVs, leading to increased ADP-
induced platelet aggregation. These studies will introduce a novel paradigm that CD39-carrying EVs prevent
pulmonary thrombosis in SCD, and lead to first-ever Precision Medicine in SCD by identifying rs3176891G as
a risk for pulmonary thrombosis.

Public health relevance
Project Narrative. Sickle cell disease (SCD) is the most common hemolytic disorder affecting African Americans. Acute pulmonary thrombosis is the underlying cause in ~20% of SCD patients hospitalized with respiratory failure; however, there is no available treatment to prevent pulmonary thrombosis in SCD. We propose to identify molecular and genetic mechanisms that trigger pulmonary thrombosis in SCD, which would enable the development of Precision Medicine for these sub-set of high-risk SCD patients.